The role of muscle contraction in gene activation and tissue regeneration

SUMMARY OF PARENT GRANT:
Regeneration is a remarkable phenomenon that is both ubiquitous and mysterious; although many different
animals are capable of replacing damaged and/or lost structures, it is unclear how these regenerative species
maintain both the cellular stability required for tissue integrity and the cellular plasticity needed to reactivate
tissue development upon injury. Moreover, as regeneration is often induced by spontaneous and imprecise
tissue damage, how do cells translate broad and sudden signals into cell-type-specific transcriptional changes?
Genomic regulators such as transcription factors and chromatin-modifying enzymes work together to
instruct cell fate during developmental processes. Although there is substantial data describing how these
factors orchestrate embryogenesis, much less is known about how they are activated to induce regeneration.
My central hypothesis is that chromatin serves as a mediator between the signaling events that are triggered
by significant tissue loss and the cellular changes they induce to activate regeneration. To uncover the
fundamental molecular mechanisms underlying this process, my laboratory studies the planarian model of
animal regeneration. Planarians are free-living flatworms with incredible regenerative capacities. They are also
amenable to genetic perturbation through RNAi, easily dissociated for single cell analyses, and encode
chromatin modifying proteins with strong homology to those in other organisms. We are particularly interested
in how some planarian cell types respond to injury by activating specific, essential, regeneration genes, while
others activate an entirely different set of loci in response to the same injury. My lab uses multiple customized
methods to isolate specific planarian cell types, both differentiated and stem cells, in order to characterize the
chromatin state of these cell types before and after injury. We also leverage data showing that RNAi depletion
of the MLL1/2 chromatin enzyme in the planarian Schmidtea mediterranea leads to loss of cilia on its outer
epithelium. In addition, we have recently isolated and characterized a new planarian species that has a unique
cilia pattern on its outer epithelium, providing an exciting opportunity to use comparative genomic approaches
to identify specific genes that are linked to this particular trait. Combining all these approaches, we aim to
dissect the functional role and molecular signaling cues contributed by specific cell types during regeneration.
The outer epithelium and other differentiated tissues are essential for planarian regeneration in large part
because they signal to a population of heterogeneous multi and pluripotent stem cells that are maintained in
adult planarians. Because these stem cells must differentiate into all needed cell types in response to missing
tissue signals, it is not surprising that they are highly plastic and transcriptionally heterogeneous. Yet it is
unknown how they create and maintain this heterogeneity in vivo. We will test the hypothesis that a conserved
chromatin signature regulates this critical feature. These studies will uncover important mechanisms underlying
both regeneration and other biological processes that require dynamic gene regulation across complex tissues.
SUMMARY OF PROPOSED RESEARCH FOR CANDIDATE:
A growing body of research in the planarian field supports the hypothesis that longitudinal muscle fibers
secrete signaling proteins that are required for the regeneration of new tissues. However, these papers largely
do not address the role of muscle contraction in this process. Nonetheless, it is known that muscle contraction
is induced immediately after injury and required for wound closure. In my lab, we are interested in how
signaling events triggered by injury lead to changes in gene expression that are required for regeneration. We
hypothesize that the muscle contraction triggered by a significant injury induces the activation of essential
tissue patterning genes. We are using chemical inhibitors, RNA interference, and physiological measurements
to test our hypothesis.
This project has been the focus of a talented undergraduate student in my laboratory, Easter Kabuya,
who graduated with a Bachelor of Science degree in Biology in December 2023. We are requesting funds to
support her as a post-baccalaureate researcher in the laboratory so that she can complete her ongoing project,
assemble it into a first author publication, and enhance her competitiveness as an applicant to M.D./Ph.D.
programs as well as future fellowships and grants. The completion of this project will not only further the career
of this candidate, but also the objectives of the parent grant by connecting injury-induced changes in a specific
tissue type with functional changes in gene expression during regeneration.

Public health relevance
Research in my lab leverages the experimental tractability and remarkable regenerative abilities of planarian flatworms to uncover fundamental molecular mechanisms that link injury-induced signals to functional changes in gene expression. An undergraduate student in my laboratory has generated preliminary data suggesting that contraction of the planarian body wall muscle may be critical for the activation of key regeneration genes, a finding that has broad implications for regenerative medicine. As post-baccalaureate researcher, she will test her hypothesis using multiple orthogonal approaches.